Epithelial Genes in Allergic Inflammation

Project Summary
Epithelial cells are the first line of defense as they interface with the environment and initiate the response to
environmental triggers. Our AADCRC is focused on elucidating the mechanisms by which epithelial cells
contribute to the pathogenesis of allergic disorders. We found that while some epithelial genes are associated
with tissue-specific disease, others are associated with specific combinations of disease and may contribute to
disease progression from one end-organ to another. It is known that allergic disorders show substantial lifetime
comorbidity. The “atopic march” concept has served as a guiding principle in our field, however, it has become
evident that only very small proportion of children follow the traditional atopic march. While early-life AD remains
a major risk factor for the development of atopic disease, there is significant heterogeneity in presentation of the
atopic march including the timing and organ(s) affected. The atopic march needs to be revised to include this
heterogeneity and incorporate the pathogenesis of the various combinations of the atopic march. Our Center is
designed to help fill this critical knowledge gap. In the last cycle of funding, we built the first US early-life
prospective longitudinal cohort of AD (Mechanisms of Progression of Atopic Dermatitis to Asthma in Children,
MPAACH) and conducted mechanistic studies to identify epithelial pathways that promote allergic inflammation
and disease. Our collective preliminary data implicate novel epithelial pathways as key drivers of allergic disease
persistence in a given tissue as well as progression from one tissue to another. Herein, we will determine how
these pathways act to promote the development, persistence, and progression of allergic and inflammatory
diseases. Further, the atopic march needs to be revised to include non-White children. The vast majority of
studies that served as the foundation for the atopic march principle were conducted in White populations, and
our data reveal marked racial differences in the current atopic march concept. MPAACH is comprised of 65%
Black children and was designed to help fill this critical need. The overarching hypothesis of this proposal is that
homeostatic mechanisms at epithelial surfaces, upon dysregulation, promote allergic inflammation and
contribute to the persistence, progression, remission and resolution of allergic disease(s). This hypothesis will
be tested by three integrated and synergistic projects focused on epithelial cell biology that combine
epidemiologic, basic, and translational research approaches to study multiple end-organs involved in allergic
responses. Integration of data across projects by the Data Integration and Analysis Core (DIAC) will provide
novel insights into a key unanswered question in the allergy field: Why is allergic inflammation restricted to one
tissue in some cases, while it progresses to involve additional tissues in other individuals? Identification of the
epithelial genes/pathways that predispose individuals to specific or shared allergic disorders will empower the
search for therapeutics aimed specifically at the epithelial surface, and the development of treatment and
prevention strategies optimized for allergic disorders alone and/or in combination.

Public health relevance
Project Narrative The overall goal of this Center is to uncover and define the mechanisms by which epithelial genes contribute to the development, persistence, progression, remission, and resolution of allergic disorders so that effective strategies can be developed to prevent the onset and/or halt the progression of allergic disease.